EFFECT OF LOVASTATIN ON GLUCOSE AND LIPID METABOLISM IN DIABETICS

The purpose of this study is to evaluate the effect of lovastatin on glucose and lipid metabolism in diabetic and non-diabetic subjects with hypercholesterolemia.